Tumor-Specific Nanocontrast Agents for Improved Detection of Pancreatic Cancer

PROJECT SUMMARY/ABSTRACT
Abstract. Pancreatic adenocarcinoma (PDAC) is a highly aggressive form of cancer that has high mortality and
late stage diagnosis. Undergoing chemotherapy and subsequent surgery for tumor resection is the only
potentially curative options for patients with PDAC. However, differentiation between benign disease, e.g.,
fibrosis, and tumor tissue is difficult. Currently, this differentiation is based on visual inspection and palpation of
the operating surgeon. This poor differentiation can often result in incomplete resection of tumor, leading to likely
reoccurrence of cancer in the pancreas or as distant metastases. Multispectral optoacoustic tomography (MSOT)
is an emerging modality which has recently entered clinical testing and exhibits high resolution, real-time, and
depth penetration suitable for intraoperative imaging. MSOT has the capability of identifying multiple molecular
agents simultaneously, but current lacks tumor-specific contrast agents for identifying cancer to provide such
information. Development of PDAC-specific contrast agents for MSOT represents the potential for improved
detection of PDAC in an intraoperative setting. While small molecule dyes and antibody-drug conjugates have
been evaluated, low signal has resulted due to non-specificity or few contrast molecules reaching the tumor. To
overcome these limitations, my objective is to: 1) develop targeted, tumor-specific nanocontrast agent (P-MSN),
and 2) test P-MSN for detection of pancreatic cancer in vivo using MSOT. Building upon my experience with
constructing mesoporous silica nanoparticles, I am proposing the development of a new, tumor-targeted
nanocontrast agent, P-MSN, which exhibits three unique features for improved PDAC tumor-specificity: 1) small
(<50 nm diameter); 2) tumor-specific cargo release with pH-sensitive (PVA-PAAm) gatekeeper; and 3)
introduction of Plectin-1 active targeting peptide. The development of a tumor-specific nanocontrast agent could
increase the accuracy of PDAC identification using MSOT compared to hemoglobin alone. I hypothesize that
through the dual-targeting of PDAC, i.e. the use of plectin-1-targeting peptide (PTP) to provide specificity to
tumor cells, and MSN gatekeeping with P(VA-AAm), to target and release contrast specifically in the acidic tumor
microenvironment, the developed MSNs will facilitate improved detection of PDAC by MSOT. To test this
hypothesis, I propose the following aims: 1) Develop a tumor-specific nanocontrast agent (P-MSN), and 2)
Assess efficacy of tumor-specific nanocontrast (P-MSN) for detection of PDAC in vivo by MSOT. The impact of
this study is the development of a pancreatic cancer specific nanocontrast agent that has potential to identify
molecular features and improve identification of pancreatic cancer using MSOT. If successful, our studies will
provide “first-in-class” pancreatic cancer specific contrast agent which could be used intraoperatively to clearly
differentiate between malignant and benign tissue to ensure complete resection of tumor in PDAC patients.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is among the deadliest cancers due to the inability to ensure complete resection of tumor during surgery. The development of strategies that specifically target pancreatic cancer have the potential for clinical translation for intraoperative surgery in efforts to improve outlooks for patients by ensuring complete resection. Preliminary results show that our prototype nanocontrast agent can be actively-targeted to deliver tumor-specific contrast agents for improved detection of pancreatic cancer with optoacoustic imaging.